2013 Carbohydrate GRC

DESCRIPTION (provided by applicant): This proposal requests partial support for a meeting on Carbohydrates as a Gordon Research Conference to be held at Mount Snow Resort in West Dover, Vermont from June 16 to June 21 in the summer of 2013. The continuing broad and long-term goals of this conference are to bring together glyco-scientists from a range of chemical and biochemical disciplines to present and discuss their latest unpublished research with the aim of defining new fundamental questions and potential answers to the field of carbohydrate research. The specific aims of this meeting will be: 1) to bring together a broad spectrum of glyco-scientists who fully represent the current and future carbohydrate scientific community; 2) to create an environment where world leaders and raising stars in carbohydrate research can present their latest results; 3) to put together a conference that reflects the most important and emerging areas in carbohydrate research areas. The significances of this application and the Carbohydrate Gordon research conference are that this conference will provide a unique international forum to bring together wide range of glycoscientists with chemistry and biology backgrounds. The health relatedness of this application is that the discussions generated will help define important questions relating to basic and applied glycosciences. It is believed that the answering of these questions will ultimately lead to the development of new carbohydrate based therapeutic and diagnostics for a broad range of human disease states.

Public health relevance
The 2013 Gordon Research Conference on Carbohydrates will bring together leaders in the field of Glycoscience and highlight new emerging areas of carbohydrate research with an emphasis on building interdisciplinary collaborations between synthetic chemists, analytical chemists, computational chemists/biologists/bio-informatician, and chemical biologists. This will include both established and new investigators and will include students and postdoctoral scholars, with every effort made to insure the conferences will include women, minorities and the disabled, who work on the study of carbohydrates. The goal of the conference is to present the current state of the art in the Glycosciences, with a particular it wil focus on a broad area of carbohydrate research, including: the development of new synthetic, computational, and analytical tools for the development of new biomedical diagnostics, vaccines, and therapeutics.